Peptide-Doxorubicin Conjugates for Mitigating Cardiotoxicity and Overcoming Drug Resistance in Cancer

PROJECT SUMMARY
Doxorubicin (DOX) is an FDA-approved anthracycline chemotherapy drug that is utilized for the treatment of a
range of cancers, such as breast, lung, ovarian, gastric, and thyroid. However, the clinical application of DOX
has demonstrated multidrug resistance and unfavorable pharmacokinetic qualities, such as low bioavailability,
rapid distribution, and excretion. Thus, a higher dose of DOX is required for chemotherapy. However, it is well
documented that higher cumulative doses of DOX lead to dose-dependent cardiotoxicity, nephrotoxicity, and
extravasation. Despite extensive research on targeted therapy systems, the safe, effective, and exclusive
delivery of DOX to target cells remains elusive. The long-term objective of this proposal is to harness the
potential of cyclic- and hybrid cyclic-linear peptide-DOX conjugates to address DOX cardiotoxicity and combat
drug resistance in cancer cells. Our preliminary data demonstrate the efficacy and low toxicity of peptide-DOX
conjugates (PDCs) against Dox-resistant and cardiac cells, respectively. We hypothesize that optimized PDCs
can effectively target and overcome DOX-resistant cancer cells while reducing cardiotoxicity, thus enhancing
therapeutic efficacy. We will pursue two Specific Aims to test this hypothesis. In Aim 1, we will investigate the
differential mechanism of cardiotoxicity mitigation and overcoming DOX-resistant cancer cells by five PDCs,
[W(RW)4K]βA-DOX, [R5K]W7-βA-DOX, [W(RW)8K]βA-DOX, [(WR)4C]-S-S-DOX, and [R5W4]K-
RRWWRLWRRLWRβA-DOX. Three primary mechanisms underpinning the cardiotoxic effects of DOX include
(i) generation of reactive oxygen species (ROS) leading to membrane damage, (ii) apoptosis in cardiomyocytes,
and (iii) modulation of intracellular calcium release. We will elucidate the mechanisms that differentiate their
cytotoxic effects on cancer cells versus cardiomyocytes. We will also evaluate the mechanism of activity of PDCs
using DOX-resistant cells that have overexpression of membrane efflux proteins. We will monitor the
internalization and intracellular trafficking of the PDCs and released DOX, and their interactions with membrane
efflux protein (e.g., P-gp) in the heart, DOX-resistant, and cancer cells. Aim 2 is focused on the in vivo evaluation
of three functionalized PDCs for DOX delivery to cancer xenograft models and the evaluation of cardiotoxicity.
These studies will involve inducing tumors in immunodeficient mice using both naïve and resistant cells. We will
evaluate the distribution, tumor-suppressive efficacy, cardiotoxicity, and safety profile of three functionalized
PDCs with PEG and folic acid or RGD. The outcomes of this project will contribute to our understanding of how
peptide structure affects both cardiotoxicity and the mitigation of DOX resistance and could greatly improve the
effectiveness and safety of DOX for cancer treatment. This project closely aligns with the missions of the National
Heart, Lung, and Blood Institute (NHLBI) and National Cancer Institute (NCI), as well as the NIH REAP (R15)
FOA. It enables undergraduate and graduate students to participate in valuable research, enriches our
institution's research milieu, and advances translational research in cardiovascular and cancer fields.

Public health relevance
NARRATIVE The proposed studies represent a comprehensive multidisciplinary plan to determine the mechanisms of cardiotoxicity mitigation and overcoming drug resistance by peptide-doxorubicin conjugates through rigorous in vitro and in vivo studies to establish a versatile platform for cancer treatment.